Exploratory Toxicology Studies in Mice Administered Natural Product ExtractsTO 03

This Task Order 03 will cover costs associated with exploratory toxicology studies in mice administered natural product extracts.